Understanding the molecular mechanisms of Akkermansia glycan-binding adhesins in shaping microbial communities and balancing intestinal inflammation in response to host signals

PROJECT SUMMARY/ABSTRACT
Akkermansia muciniphila is a bacterial resident of the human intestine that is associated with protection from
chronic inflammatory diseases such as inflammatory bowel diseases, colorectal cancers, and type-2 diabetes.
The molecular mechanisms that determine how A. muciniphila inhabits the intestine and how it promotes host
health are not known. A. muciniphila grows in dense aggregates in tight association with the glycan-rich mucin
lining of the intestine. When cultured in mucin medium, A. muciniphila produces anti-inflammatory compounds
and stimulates other glycan-coated gut microbes like Ruminococcus gnavus to produce butyrate, a fermentation
byproduct with therapeutic properties. The board and long-term objective of this project is to learn how the
glycan environment of the intestine shapes A. muciniphila’s anti-inflammatory activities and decode species-
level mechanisms that drive variability among clinical isolates. This work has wide-reaching implications in fields
such as probiotic and therapeutic development aimed at treating inflammatory diseases. The focus of this
proposal is to develop a molecular understanding of how A. muciniphila strains regulate a diverse group of
glycan-binding cell surface adhesins referred to as PbH1-containing adhesins (PbHAs) to engage with the mucin
environment of the intestine, to interact with and manipulate butyrate fermentation in other symbionts, and to
modulate innate immune pathways in the host. In Specific Aim 1 I will engineer a zebrafish bacterial symbiont
to express each of the seven diverse PbHAs encoded by two A. muciniphila species of interest (MucT and
AKK2750) and test how expression shapes their aggregation properties in culture and influences their spatial
organization in the larval zebrafish gut. Further, I will use experimental evolution to uncover the genetic pathways
that drive MucT and AKK2750 aggregation in mucin medium. Specific Aim 2 will investigate the role of PbHAs
in co-aggregation with R. gnavus and determine how MucT and AKK2750 mucin-sensing and co-aggregation
with R. gnavus influence butyrate fermentation. Lastly, Specific Aim 3 will use a zebrafish model of microbe-
induced intestinal inflammation to identify PbHAs and other species-specific factors that reduce inflammation
and promote intestinal health. I will use a pathogen-targeting PbHA to design therapeutic beads that bind and
deplete an intestinal pathogen and restores gut health. The molecular insights I will discover, research reagents
I will generate, and skills I will acquire through these studies will position me to establish my own independent
research laboratory investigating the molecular mechanisms of microbiome-mediated human health.

Public health relevance
PROJECT NARRATIVE Understanding how healthy interactions between intestinal bacteria and the immune system are established and maintained is important for developing treatments for intestinal inflammation diseases like inflammatory bowel diseases and colorectal cancers. Akkermansia muciniphila is a human intestinal bacterium that produces anti-inflammatory factors in response to the diverse sugars that line the gut. This project will explore how Akkermansia senses and binds to sugars on the gut lining and on other gut bacteria and determine how these pathways shape intestinal health.